Evaluating the impact of malaria on immunogenicity of the Ebola virus vaccine

PROJECT SUMMARY
Plasmodium parasites, the causative agents of malaria, continue to be major drivers of infectious disease-related
morbidity and mortality. Plasmodium evades sterilizing immunity in part by inducing proinflammatory changes
that interfere with the orchestration of humoral immunity targeted towards parasite-specific antigens. This is
seemingly not limited to parasite-specific immunity, as malaria can interfere with the efficacy of other routine
vaccinations; the underlying mechanism of these impairments is poorly understood. Plasmodium parasites are
endemic throughout Central and West Africa, regions in which highly pathogenic Zaire Ebola virus (EBOV)
episodically causes outbreaks. An FDA-approved, live-attenuated, recombinant vaccine called ERVEBO
stimulates antibody responses directed against the EBOV glycoprotein (GP) and has shown promise during
EBOV outbreaks in Guinea in 2016 and Democratic Republic of the Congo (DRC) in 2019. Recent studies in the
DRC suggest that current ring vaccination with ERVEBO can be highly porous; ~30% of EBOV-infected
participants in a recent antiviral trial in the DRC were prior recipients of the vaccine. A possible explanation for
this vaccine failure is acute Plasmodium infection of vaccine recipients at the time of vaccination, resulting in
reduced immune responses to the vaccine. Utilizing experimental Plasmodium infection and clinically relevant
vaccine administration strategies in a mouse model, my preliminary data show that mice that are parasitemic at
time of vaccination exhibit dramatically reduced levels of EBOV GP-specific antibodies, reduced vaccine-induced
germinal center (GC) formation in the draining lymph node (LN), and reduced vaccine load in the draining LN.
These data inform our hypothesis that Plasmodium impairs multiple steps in the generation of a robust humoral
response to ERVEBO, which will be tested through the following specific aims: 1) determining the underlying
mechanistic impact of Plasmodium infection on ERVEBO-induced GC responses in the draining LN, and 2)
determining the impacts of Plasmodium on antibody producing plasma cells and the functionality of EBOV GP-
specific antibodies. Success of these studies will reveal mechanisms through which Plasmodium can impair
ERVEBO vaccine responses and provide clinically actionable approaches to overcome this impairment.
The experiences, techniques, mentoring, and concepts in this proposal were specifically tailored to Mr. Jonah
Elliff and his training goals. As a developing researcher interested in improving strategies to treat and prevent
severe infectious disease, Mr. Elliff is performing these studies through the Medical Scientist Training Program
(MSTP) at University of Iowa under the scientific mentorship of Drs. Wendy Maury and Noah Butler, who provide
individualized training at the intersection of virology, immunology, and vaccinology. Longer term plans for Mr.
Elliff will be to complete his MSTP training and pursue a research residency in internal medicine, followed by an
infectious disease fellowship, and ultimately a faculty position at an academic research center to continue
investigating virus-host interactions and immune responses that control viral infections.

Public health relevance
Project Narrative Studies from the Zaire Ebola virus (EBOV) outbreak in West Africa suggested that the FDA-approved EBOV vaccine can be highly effective; however, more recent data from the Democratic Republic of the Congo revealed that EBOV vaccine failure rates may be as high as 30%. We postulate that acute Plasmodium parasitemia that is prevalent in Central Africa decreases immune responses to the FDA-approved vaccine. Here, we use a mouse model to mechanistically define the effect of acute Plasmodium infection on the efficacy of EBOV vaccine.